Sibling-Support for Adolescent Girls (SSAGE): A whole-family, gendertransformative approach to preventing mental illness among forcibly displaced adolescent girls

Project Summary
Forcibly displaced adolescents face increased risks for mental illness and distress, with
adolescent girls disproportionately affected in part due to the heightened gender inequity that
often accompanies forced displacement. Although the family unit has the potential to prevent
mental illness and promote healthy development in adolescents, few family interventions have
employed a gender transformative approach or included male siblings in an effort to maximize
benefits for adolescent girls. Therefore, we propose to assess an innovative whole-family and
gender transformative intervention—Sibling Support for Adolescent Girls in Emergencies
(SSAGE)—to prevent mental health disorders among adolescent girls in Colombia who were
recently and forcibly displaced from Venezuela. The proposed R34 study will adapt the SSAGE
curriculum through human-centered design with a range of stakeholders, including Venezuelan
refugees, Colombian returnees and relevant civil society organizations. The proposed study will
then employ a hybrid type 1 effectiveness-implementation pilot randomized control trial
(RCT) to test the program’s effectiveness and mechanistic pathways as well as to explore
determinants of implementation in order to establish the feasibility, acceptability, and fidelity of
SSAGE. To address these aims, we will enroll 180 recently arrived, forcibly displaced
adolescent girls in an RCT and examine the program’s effectiveness on the prevention of
mental illness (through reduction in anxiety, depression, interpersonal sensitivity, and
somatization symptoms) one-month post-intervention. We will use contextually adapted and
piloted measures to collect additional data on the hypothesized mechanistic pathways, including
family attachment, gender equitable family functioning, self-esteem, and coping strategies. The
implementation evaluation will employ mixed methods to assess the program’s feasibility,
acceptability, fidelity and barriers and facilitators to successful implementation. Potential findings
can support humanitarian program implementation, as well as inform policy to support
adolescent girls’ mental health and to prevent the myriad disorders that can arise as a result of
exposure to displacement, conflict, and inequitable gender norms in their households and
communities.

Public health relevance
Project Narrative This proposed study will use a human-centered design to adapt a whole-family, gender transformative intervention to prevent mental health disorders among adolescent girls (between 13 and 19 years) who are forcibly displaced from Venezuela to Colombia. The study will employ a hybrid type 1 effectiveness-implementation pilot randomized control trial to measure the effectiveness of the adapted program, while also assessing its acceptability, feasibility, and fidelity and identifying barriers and facilitators to implementation.